Respectful Communication and Patient Portal Usage in Pregnant People of Color

Project Summary
Pregnant people of color consistently report poor communication, being dismissed, ignored, discriminated
against and disrespected. Racially-based mistreatment contributes to worse experiences and increased labor
interventions. Improvements in patient-provider communication (PPC) are urgently needed in prenatal care. With
the increasing numbers of digital modalities, such as the patient portal, it is essential to examine the impact of
these digital tools on PPC. Patient portals have emerged as an effective and valuable strategy to improve PPC
providers in the general population. Research on patient portal usage in the general population, including in
pregnant people, demonstrates lower portal usage in communities of color creating the digital divide. One aspect
of this divide is digital health literacy (DHL). Few studies have examined DHL in pregnancy in the U.S. No study
has examined the relationship between PPC, patient portal usage and DHL in pregnant people of color. With the
persistent perinatal health inequities and the rapid integration of digital health tools, the time is now to better
understand patient-provider communication, patient portal usage and digital health literacy in pregnant people
of color. The long-term goal of the proposed research is to improve respect and quality in perinatal care through
the creation of an inclusive, culturally relevant digital health intervention to address PPC for pregnant people of
color. The specific aims are: Aim 1 - quantify the relationships between patient-provider communication, patient
portal usage and digital health literacy in pregnant people of color; and Aim 2 - identify the facilitators and barriers
to optimal digital communication in pregnant people of color. This multimethod study will recruit 130 self-identified
pregnant people of color from an urban safety net hospital. Survey data will be collected on demographic and
clinical information, as well as participant perceptions of PPC in pregnancy, patient portal usage and digital
health literacy. Exploratory qualitative questions will be posed at the end of the survey to inquire about facilitators
and barriers to optimal digital patient-provider communication. For Aim 1, regression analysis will examine the
associations among respectful patient-provider communication, digital health literacy and patient portal usage in
pregnant people of color, after controlling for covariates. In Aim 2, thematic analysis will be applied to understand
how optimal communication develops through patient portal utilization by individual experiences of the
participants. This research is significant because it proposes to examine a potentially modifiable influence on
PPC, a public health priority. This study addresses the NINR’s research lenses to advance health equity and
social determinants of health research. Without data on how patient-provider communication within the patient
portal and utilization barriers faced by pregnant people of color, the benefit of this digital modality will be
inequitable and disparities exacerbated.

Public health relevance
Project Narrative Pregnant people of color consistently report being dismissed, ignored, discriminated against and disrespected within the perinatal care system, contributing to persistently high perinatal mortality and morbidity rates in the United States. Healthy People 2030 aims to decrease the proportion of adults who report poor communication with their health care providers and to improve digital communication between patients and providers. This proposal is relevant to public health as it seeks to measure the relationship between patient-provider communication, patient portal usage and digital health literacy and to identify the facilitators and barriers to optimal digital health communication in pregnant people of color.